Phosphatases in Systemic Autoimmunity

Abstract
!
Systemic lupus erythematosus (SLE) presents profound T cell effector dysfunction. Interleukin-2
(IL-2) deficiency accounts for the increased infection-related morbidity and mortality rates, the
defective regulatory cell (Treg) function and compromised ability to eliminate autoreactive T
cells. In parallel, T cells produce increased amounts of interleukin-17 (IL-17) which is involved
in tissue inflammation and damage. Protein phosphatase 2A (PP2A) is the first serine/threonine
phosphatase recognized to contribute first to human SLE and later to murine lupus
immunopathology. It is a trimolecular enzyme consisting of scaffolding, catalytic and regulatory
subunits. We have shown that PP2Ac expression is increased in patients with SLE and that it is
central to a number of signaling pathways including the suppression of the production of IL-2
and the enhancement of the production of IL-17 and that the regulatory subunit Bβ regulates IL-
2 deprivation-induced T cell death and is decreased in SLE patients. A mouse lacking PP2A in
Tregs develops severe inflammation and autoimmunity because PP2Ac is needed for the
suppression of the mTORC1 pathway. Using novel mice and molecular tools the proposed
work will test the hypothesis that PP2Ac represents a main contributor in the
immunopathogenesis of SLE and autoimmunity in general by 1) determining the importance of
PP2A expression in Tregs in the regulation of the autoimmune response and related pathology;
2) determining the importance of PP2A expression in conventional T cells in the regulation of
the autoimmune response and related pathology; and 3) establishing the aberrant expression of
the regulatory subunit Bα in human SLE and determine how it contributes to IL-17 production.
This project will generate novel concepts (differential regulation of central immune functions by
PP2A, regulation of distinct functions by specific regulatory subunits) and new informative mice
(mice lacking PP2A in T cell subsets and mice lacking regulatory subunits in T cells).
Understanding the molecular complexity which underlies the expression of systemic
autoimmunity is significant to the extent we wish to correct important pathways to treat patients.
The ability to carry out parallel studies in mice and humans increases significantly the
translational value of our work.
!
!
!

Public health relevance
Systemic lupus erythematosus (SLE) is an autoimmune disorder of indeterminate etiology characterized by profound T cell effector dysfunction. Infection-related morbidity and mortality rates are high among patients with SLE and it is attributed to disease activity, the use of immunosuppressive drugs and deficient cell- mediated cytotoxic responses that are associated with decreased expression of interleukin-2. Understanding the molecular mechanisms that cause immune dysregulation and associated pathology will generate novel information which will guide approaches to correct its production and help decrease the rate of infections by restoring immune cell function.